Task A95: Minimal Inhibitory Concentration (MIC) Testing and Efficacy Studies in a Rabbit Model of Treponema Pallidum Infection

This contract provides for the development of new and refinement of existing models of infectious diseases and may include evaluation of candidate countermeasures.